Nephrology & Urology Workforce Pipeline

ABSTRACT
There are an estimated 50 million Americans with chronic kidney disease (CKD), and the care provided to people
with CKD and end stage kidney disease exceeds $114 billion annually. Despite these numbers, recent data
indicates that there is a significant workforce shortage in the field of nephrology and that the total number of
grants submitted to the NIH focused on kidney and urologic diseases and disorders has decreased over the past
decade. This dichotomy creates a significant need to reverse the current trends and increase the number of
trainees interested in pursuing a career in nephrology and urology that includes an NIDDK-related research
focus. To begin to address these important issues, we propose the development of a new Student Urinary Tract
Program in Education and Research (SUPER) Summer Program for undergraduate students with a strong focus
on diversity. This program will provide new educational, laboratory and clinical experiences for undergraduate
students promoting a better understanding of kidney and urinary tract diseases as well as careers in Nephrology
and Urology. In addition, the SUPER-Summer Program is designed to integrate into a wide range of pre-existing
training programs at The Ohio State University and Nationwide Children’s Hospital providing a seamless NIDDK-
focused workforce pipeline. We strongly believe that creating this innovative and well-structured SUPER-
Summer Program focused on nephrology and urology related topics will capture student interest early in their
career development - thereby increasing the potential workforce population and diversity creating a strong
foundation for the next generation of NIDDK-research focused clinicians and scientists.

Public health relevance
PROJECT NARRATIVE This proposal seeks to provide a transformative 12-week summer education, research and clinical experience that encourages undergraduate students to pursue careers that will advance progress in kidney and urinary tract related research and career development. This program is specifically designed to attract minorities and students from underserved and disadvantaged communities with the long-term goal to reduce heath disparities and increase the workforce in the fields of Nephrology and Urology.